Quantitative super-resolution imaging to map the multi-scale functional organization of cells

Project Summary
The long-term goal of this proposal is to understand the mechanisms that regulate sub-cellular organization and
the significance of this organization to organelle and cell function. Cells are highly compartmentalized at multiple
length scales. At the micron scale, organelles are organized within the cytoplasm and occupy specific sub-
cellular zones. Proteins and nucleic acids organize into assemblies at the nanometer scale in the cytosol, nucleus
and on cellular membranes to ensure high fidelity of biochemical reactions. This highly orchestrated
spatiotemporal organization maintains cellular homeostasis. Not surprisingly, disruptions to the spatiotemporal
organization of organelles, proteins and nucleic acids are hallmarks of diseases. In this context, we seek to
address three key biological questions: 1. How do molecular assemblies of motor and adapter proteins regulate
the transport and spatial positioning of organelles and how are these assemblies disrupted in diseases. 2. How
is the molecular identity of organelles such as lysosomes, in turn, linked to organelle positioning and dictate
organelle function in health and disease states? 3. What is the cause/consequence relationship between the
spatial organization and physical compaction of the genome within the nucleus, the epigenetic modifications,
and gene activity? To address these questions, we will take an innovative approach of combining cell biological
tools with new, advanced, and quantitative microscopy methods that enable us to visualize the spatial
organization of cells in situ and with near molecular spatial resolution. This proposal builds on major advances
made by my group in the past 12 years in developing quantitative advanced microscopy tools including
quantitative, multiplexed super-resolution microscopy. These methods make it possible to address the molecular
scale questions that we are asking in the cell context and with unprecedented quantitative detail. We have used
these tools to visualize organelles moving along individual microtubule filaments inside cells, protein
nanoplatforms forming on microtubules, inside the cytosol and on organelle membranes, and the folding of the
chromatin fiber within the nucleus. These approaches provided new insights into how the microtubule
cytoskeleton and motor proteins collectively regulate organelle transport and how the folding of chromatin relates
to cell identity under physiological and pathological states. This proposal will build on our advances to elucidate
how multiple molecular parts assemble into functional transport units to regulate the positioning and ultimately
the function of organelles. We will further map the spatial proteome of these organelles to determine how their
molecular identity is linked to organelle positioning and function. Finally, we will seek to address the causal
relationship between chromatin structure and function. These areas and our method development integrate
synergistically to advance our understanding of how sub-cellular organization emerges, and the importance of
this organization for cell physiology and pathology.

Public health relevance
Project Narrative: The proposed research is relevant to public health as we will use innovative approaches that probe the spatial organization of cells at unprecedented quantitative detail to uncover novel mechanisms by which the spatial organization of sub-cellular organelles and the genome impacts organelle and gene function under physiological and pathological conditions. The project is relevant to NIH's mission as it will open new horizons for studying how cellular homeostasis is disrupted in diseased cells.